The role of salt inducible kinases in parathyroid hormone action in bone

Project Abstract
Osteoporosis is a major public health problem in our aging population. New bone anabolic strategies to treat
this disease are desperately needed. Parathyroid hormone (PTH) is a central regulator of calcium
homeostasis. Through its rapid actions in bone, PTH quickly liberates skeletal stores of calcium and maintains
normal blood calcium levels. In addition, PTH also stimulates bone formation, and this property is exploited in
the form of once daily injections (teriparatide and abaloparatide) for osteoporosis treatment. Widespread use of
PTH therapy is limited by the need for daily injections. In addition, we still do not fully understand why
intermittent PTH effectively builds bone while continuous hyperparathyroidism leads to loss of bone mass and
some suppression of osteoblast activity. In this research program, we will understand how PTH stimulates
bone formation and then use that information to develop next generation orally available bone anabolic
therapies. Towards those goals, we recently defined a role for salt inducible kinases (SIKs) as key intracellular
mediators of the actions of parathyroid hormone in bone cells. PTH signaling via cyclic AMP and protein kinase
A blocks SIK2 and SIK3 activity in cells. Accordingly, genetic and pharmacologic experimental strategies that
block SIK2/SIK3 activity effectively mimic the actions of PTH in bone. Here, in Aim 1, we will develop, evaluate,
and test ‘next generation’ orally available compounds that block SIK2/SIK3 action and boost bone formation
and bone mass in preclinical hypogonadism-associated osteoporosis models. In doing so, we will merge
genetic and pharmacologic approaches to ensure that these compounds indeed act via their intended targets
(SIK2 and SIK3) to stimulate bone formation. Having demonstrated therapeutic efficacy of novel small
molecule SIK2/SIK3 inhibitors, next we will define their mechanism of action in bone cells in Aim 2. Unbiased
phospho-proteomic profiling revealed potential control of phosphoinositide 3-kinase and AKT signaling by the
PTH/SIK pathway. This observation may explain why continuous hyperparathyroidism fails to fully stimulate
bone formation by osteoblasts. Here we will study how PTH/SIK signaling intersects with the AKT pathway in
bone cells at the level of cellular energetics, and then use this information to test the model that reduced AKT
activity helps explain bone loss due to continuous hyperparathyroidism. Taken together, these inter-related
Aims will elucidate novel signal transduction models in bone cells and define the mechanism of action of a
new, orally-available osteoporosis bone anabolic therapy.

Public health relevance
Project narrative Osteoporosis is a major public health problem, and orally-available treatments that stimulate bone formation are lacking. We have identified a new pathway that promotes bone formation. Here, we will define how this bone building pathway interacts with other hormones, and develop this novel approach to treat osteoporosis.